Paramedic Evaluation for Acute COPD Exacerbation: the PEACE Intervention

PROJECT SUMMARY
Chronic Obstructive Pulmonary Disease (COPD) is a leading cause of patient morbidity and mortality in the
United States, causing 150,000 deaths, 873,000 emergency department visits, and 700,000 hospitalizations annually.
COPD exacerbations diminish patient quality of life, widen health disparities, and strain acute care resources.
Frequent assessment and early treatment prevent severe COPD exacerbations and emergency services encounters.
However, strategies for optimizing timely, effective evaluation and intervention for acute disease symptoms are
lacking. Mobile integrated health (MIH) programs, which deploy highly trained paramedics supervised remotely
by physicians into the community to care for patients in their homes, may improve COPD care delivery by
overcoming barriers to timely evaluation and treatment. There have been no prior investigations of the
implementation or effectiveness of MIH initiatives to manage COPD exacerbation. In this proposal, I seek to
implement, refine, and evaluate the Paramedic Evaluation for Acute COPD Exacerbation (PEACE) intervention.
This program dispatches community paramedics into patients' homes on-demand, in collaboration with
ambulatory teams to manage COPD exacerbation proactively. I have evaluated barriers and facilitators to the
adoption of MIH to manage COPD exacerbation. I have also demonstrated the feasibility and safety of an MIH
program to care for acutely ill, medically complex adults. Using my findings from this preliminary work, I have
designed a prototype intervention for managing acute COPD exacerbation. My research plan includes three aims:
Aim 1: Test and refine the prototype PEACE intervention to manage COPD exacerbation in community-
dwelling adults with moderate to severe COPD. Aim 2: Complete a pilot randomized controlled trial with 50
patients to evaluate the feasibility and preliminary effect of the intervention, and Aim 3: Evaluate
implementation, of the PEACE intervention using the PRISM implementation framework. My career goal is to
lead hypothesis-driven research that investigates mobile community-based healthcare delivery strategies to
improve the lives of patients living with COPD. To help me achieve my aims and career goals, I have developed
a training plan that includes: 1) acquiring training and experiential skills in implementation and dissemination
methods, 2) obtaining advanced skills in pragmatic clinical trial design and analytic techniques, and 3)
enhancing leadership, grantsmanship and writing skills. I will achieve these goals through directed coursework,
focused seminars, and practical experience. I am well supported by a highly experienced team of mentors and
advisors. At the end of this mentored career development award, I will have an enhanced intervention, robust
preliminary data, and a refined research strategy, well-positioning me to perform an R01-funded multi-center
trial as an independent investigator.

Public health relevance
PROJECT NARRATIVE Chronic obstructive pulmonary disease (COPD) is the third leading cause of mortality worldwide annually and effective strategies to quickly detect and aggressively manage acute COPD exacerbations are lacking. Dr. O'Connor has demonstrated that mobile integrated health interventions are feasible, safe, and expedite care access for patients experiencing acute COPD exacerbation. This career development award will provide her with the training to refine, implement and evaluate a community-based mobile integrated health intervention, called the Paramedic Evaluation for Acute COPD Exacerbation (PEACE) intervention, for the management of COPD exacerbation in community-dwelling adults.